A Pragmatic Trial of Emotional Awareness and Expression Therapy for Veterans with Chronic Pain

PROJECT SUMMARY/ABSTRACT
Chronic pain is present in nearly one-third of Veterans and is frequently accompanied by comorbid trauma and
mental health symptoms. Emotional awareness and expression therapy (EAET) is an evidence-based
psychological treatment for chronic pain that was developed to directly target comorbid trauma and mental
health symptoms with the goal of reducing or eliminating chronic pain. Eleven controlled and uncontrolled
efficacy trials of EAET in Veterans and civilians have shown EAET can produce robust effects on improving
outcomes that include pain severity, pain interference, depression, anxiety, and post-traumatic stress disorder
(PTSD) symptoms. Consequently, EAET was recommended as a Pain Management Best Practice by the U.S.
Department of Health & Human Services in 2019. Moreover, in two single-site efficacy trials conducted at VA
Greater Los Angeles Healthcare System, EAET was found to be superior on several outcomes to gold-
standard cognitive behavioral therapy for chronic pain (CBT-CP) among older Veterans with chronic pain. Yet
these more tightly controlled trials may not reflect the true effectiveness of EAET when implemented by diverse
clinicians. The overall goal of the proposed project is to conduct a rigorous and comprehensive evaluation of
EAET delivered in usual care settings. The project will proceed in two phases. During a 1-year UG3 phase,
clinicians at 7 geographically diverse VA healthcare systems will be trained in EAET via an EAET learning
collaborative, and an open pilot of EAET will be performed at each site to confirm feasibility. In addition, a
formative evaluation will be conducted to engage clinicians, administrators, and Veterans and to identify
barriers and facilitators to implementation. During a 4-year UH3 phase, a multisite pragmatic randomized
controlled superiority trial of group-based EAET compared to group-based CBT-CP will be conducted among
672 Veterans with chronic musculoskeletal pain. The aims are to determine whether Veterans randomized to
EAET versus CBT-CP experience improved pain severity (primary outcome), pain interference, functioning,
quality of life, depression, anxiety, PTSD symptoms, and sleep; and decreased use of opioid pain medications
and unhealthy substance use from baseline to 10 weeks (primary endpoint), 6 months, and 12 months after
enrollment. Outcomes will also be compared for those who do or do not have comorbid mental health
diagnoses (i.e., VA service-connection for depressive disorders, anxiety disorders, and PTSD) and for men
compared to women Veterans. In addition, a longitudinal process evaluation will support the development of an
implementation toolkit for scaling, and the effects of EAET and CBT-CP will be compared on healthcare use
and costs, including a cost-effectiveness evaluation from the VA healthcare system perspective. Findings may
promote a paradigm shift in the treatment of chronic pain that could influence policy and guidelines.

Public health relevance
PROJECT NARRATIVE Chronic pain is common in Veterans, and these individuals frequently experience comorbid trauma and mental health symptoms that lead to greater pain, disability, and distress. Emotional awareness and expression therapy (EAET) is a treatment with strong evidence from 11 tightly controlled clinical trials indicating that it can reduce or even eliminate chronic pain and comorbid mental health symptoms, and yet, its effectiveness when delivered by diverse clinicians in real-world clinical settings is unknown. This project will implement EAET into clinical care in 7 VA healthcare systems and then compare it to the leading alternative, cognitive behavioral therapy for chronic pain, in a pragmatic multisite randomized trial with 672 Veterans.